Triage of Developmental and Reproductive Toxicants using an In vitro to In Vivo Extrapolation (IVIVE)-Toxicokinetic Computational modeling Application

PROJECT SUMMARY
A significant shift in the safety assessment of environmental chemicals is ongoing. This shift includes a reduction,
or in some cases elimination, of traditional toxicity testing in animals with the implementation of new approach
methodologies (NAMs). Although these emerging NAMs provide an attractive means for identifying teratogens
and other developmental toxicants, the absence of a quantitative framework for relating in vitro effects to
equivalent in vivo human exposures limits their use for public health. Here, we develop a tiered approach that
integrates existing pharmacokinetic models for pregnancy into a computational application that can be adapted
to current and emerging NAMs for developmental toxicity. The primary aim of the proposed project is to deliver
an out-of-the-box computational solution for predicting the dose-response of possible human health effects by
performing in vitro-to-in vivo extrapolation (IVIVE). In Specific Aim 1, we will design a web based computational
application, DRIIVE for the Developmental and Reproductive In Vitro to In vivo Extrapolation, that will perform
forward- or reverse-dosimetry using physiologically based pharmacokinetic (PBPK) modeling within a tiered
framework bridging multiple levels of biological complexity. This framework will allow us to better account for
chemical space and exposure routes relevant to environmental toxicants. In Specific Aim 2, the work will
culminate in a case study to take industry-relevant compounds through the defined IVIVE workflows and
compare the outcomes to in-life data. Our proposal will reduce the reliance on current in vivo developmental
toxicity and provide a much-needed framework for the next generation of chemical safety assessment.
Successful completion of this Phase I project will result in a model that will undergo further development and
commercialization in Phase II, with the ultimate goal of providing an IVIVE computational model to our customers.
This developmental toxicity product fits into the existing NAM products that we offer that reduce reliance on
current in vivo animal models.

Public health relevance
PROJECT NARRATIVE Embryo-fetal development tests (OECD 414) are expensive ($100,000+/study) and use an exorbitant number of animals (560/study); further, recent reports show that the power of animal models to predict developmental effects in humans is low. A major challenge of implementing in vitro models in a safety decision framework is understanding the quantitative aspects of compound dose-response at a specific target site during a specific "window of susceptibility" along the reproductive/developmental axis. ScitoVation is leveraging our decades of experience in pharmacokinetic modeling to design a web-based computational application, DRIIVE (Developmental and Reproductive In Vitro to In vivo Extrapolation), that will perform in vitro to in vivo extrapolation (IVIVE) using physiologically based pharmacokinetic (PBPK) modeling within a tiered framework bridging multiple levels of biological complexity.